The Effect of Alcohol and High Fat Diet on Kupffer Cell Function

PROJECT SUMMARY
Alcohol- and obesity-related liver disease are the leading cause for liver transplant in the United States.
Steatohepatitis describes a state of liver inflammation and lipid accumulation that is seen in both disease
states. Uniquely, patients with alcohol-related liver disease can suffer from a state of acute on chronic liver
failure known as “alcoholic hepatitis”. The reasons for why a similar phenomenon is not present in obesity-
related fatty liver disease is not understood. We have been able to replicate a liver failure-like state seen in
human “alcoholic hepatitis” by ablating mature Kupffer Cells in a mouse model fed a high fat and alcohol diet.
We have also shown that over an extended course, mouse fed a high fat diet with alcohol spontaneously lose
embryonically derived Kupffer Cells leading to a paucity of mature KCs. In obesity-related steatohepatitis
models, embryonic Kupffer Cells are similarly lost, but these are replaced by maturing monocyte-derived KCs
so there is no net loss of mature Kupffer Cell function. Thus, our hypothesis is that mature Kupffer Cells are
depleted during alcohol conditions and although they are replaced, their replacement populations are unable to
fully transition towards this mature state, leading to a loss of homeostasis and providing a platform for
worsening disease states including “alcoholic hepatitis”. We will test this hypothesis with 2 specific aims. Aim 1
will fate map liver macrophages using a lineage tracer mouse model to define their embryological origin and
create an identifying signature that we will use to examine human models of alcohol- and obesity-related liver
disease. Aim 2 will evaluate the assess these macrophage subsets ex vivo and use co-culture systems and
exosome isolation techniques to determine how these macrophages effect hepatocyte function. We anticipate
that 1) monocyte derived macrophages from our alcohol model will display some similarities to the
transcriptome of embryonic Kupffer cells but will lack specific markers of full maturation and tolerogenic signals
and 2) this subset will this be more inflammatory and unable to maintain a homeostatic environment when
challenged in co-culture environments. The findings of this study will help us further define the pathogenesis of
alcohol-related liver disease and provide information on new targetable pathways for treatment. As a clinical
gastroenterology fellow in the physician scientist training pathway, my goal is to become a successful
independent investigator leading a research team focused on elucidating immunological pathways within the
gut-liver axis as it relates to health and disease. The research training plan addresses gaps in my research
experience by reinforcing technical and theoretical skills I have previously developed, while also driving my
research skillset forward by learning new techniques in a closely mentored environment.

Public health relevance
PROJECT NARRATIVE Alcohol- and obesity-associated liver disease present across a wide clinical presentation spectrum, with both etiologies now being the leading cause for liver transplantation in the United States. While obesity produces a slowly progressive liver disease, alcohol can also lead to sudden liver failure called “alcoholic hepatitis”. This study intends to investigate how alcohol and obesity-related fatty liver produce different changes in the liver immune system and the implications of these for prevention of liver disease.